Structural study of Eph receptors and ephrins

DESCRIPTION (provided by applicant): The Eph receptors represent the largest family of receptor tyrosine kinases. The Eph receptors and their ephrin ligands are widely expressed during development and in the adult organism, playing important roles in axon guidance, vasculogenesis and cell migration. Eph receptors are unique among other receptor kinases in that they fall into two subclasses with distinct ligand specificities, and in that they can also function as ligands activating bi-directional signaling. Understanding the mechanism of Eph/ephrin signaling requires a detailed structural and biophysical characterization of the Eph receptors, the ephrins, and their interactions with each other and with other regulatory proteins. The specific aims of our proposed investigations are: 1) Structural characterization of full Eph ectodomains alone and in complex with ephrins; 2) Structural characterization of the interactions of EphB2 with the NMDA Receptor and amyloid precursor protein derived Aβ; 4) Production and structural characterization of functional full-length Eph receptors.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Eph receptors are the largest receptor tyrosine kinase family. The Ephs and their ephrin ligands are expressed in many tissues during development and in the adult organism and play important roles in diverse processes, including neuronal development, axon guidance, cell migration, tumor progression and metastasis. Our proposal integrates the use of X-ray crystallography with other biophysical, biochemical and cell-biological approaches to study how these molecules recognize and interact with each other, and with other regulatory proteins to activate cell-cell signaling. Currently there are no available crystal structures for any full-length RTK and our long-term goal is to determine the structures of transmembrane Eph receptors and their complexes with ephrins. Ephs are also central players in the crossroads of memory, cognition, and synapse function and malfunction, and that their misregulation leads to neurologic and psychiatric disorders. However, there are no detailed studies establishing the precise molecular mechanism of interaction between Ephs and the NMDA receptor or the amyloid precursor protein derived Aβ. This lack of knowledge has hampered efforts to specifically target these interactions for therapeutic purposes. We, therefore, will carry out detailed biochemical and structural studies on the EphB2/NMDA and EphB2/Aβ interactions.